Cognitive and Brain Changes in Preclinical Alzheimer's Disease

The pathogenesis of Alzheimer’s disease (AD) remains unclear, though there is growing support for a
synergistic relationship between vascular dysfunction and accumulation of amyloid-β and neurofibrillary
tangles. Cerebrovascular disease (CVD) risk factors are prevalent in the VA population, have been linked to
cognitive decline and higher risk for dementia, and may represent potential targets for remediating age-related
cognitive decline. [CVD risk factors are associated with peripheral vascular (e.g., increased pulse wave velocity
[PWV] indicating arterial stiffness) and cerebrovascular changes (e.g., reduced cerebral blood flow [CBF];
decreased cerebrovascular reactivity [CVR] indicating reduced ability of the cerebral vasculature to adjust
CBF).] Cerebral blood flow (CBF) is tightly coupled with metabolism underlying cognition by increasing local
delivery of oxygen and glucose to support neural function, and as such is an indirect measure of neural activity
and vascular function. [Animal models suggest reduced CBF (aka, hypoperfusion) contributes to AD-like
neurodegeneration by increasing amyloid-β accumulation and tau phosphorylation--the hallmark
neuropathology of AD. Translating these findings to humans is critical to identify and refine biomarkers of AD
and ultimately improve early detection and treatment.] We have shown altered CBF in prefrontal and medial
temporal lobe regions in older adults at genetic (APOE ε4 carriers) or cognitive (mild cognitive impairment;
MCI) risk for AD that is associated with memory and executive function, implicating CBF as a potential
biomarker of AD. This application aims to elucidate the link between the vascular and neurodegenerative
pathophysiological process of AD and the emergence of clinical symptoms to lead to an improved mechanistic
understanding of cognitive decline. Thus, the current application: [1) examines the association between
neurovascular (CBF) and cerebrovascular (CVR) function and cognition in at-risk older Veterans and tests
potential AD-related mechanisms (e.g., cerebral spinal fluid [CSF] AD biomarkers) that mediate this
relationship, 2) examines whether cerebrovascular function moderates the relationship between CBF and CSF
biomarkers, and 3) examines moderating effects of individual risk factors (e.g., increased arterial stiffness,
elevated sedentary time, APOE ε4).] This study will examine cognitive, vascular, and brain function in 120
English-speaking non-demented Veterans aged 65+ with at least 2 CVD risk factors, placing them at increased
risk for cognitive decline. Assessments include well-validated and standardized cognitive testing (e.g., NIH
Toolbox), state-of-the-art MR imaging (to measure CBF and CVR), comprehensive vascular function
assessment (including carotid-femoral pulse wave velocity, blood pressure, carotid ultrasound), lumbar
puncture to assay CSF AD biomarkers (including Aβ42, p-tau181, and total tau), accelerometry to assess
physical activity/sedentary level, and APOE genotyping. [This novel proposal aims to test the central
hypothesis that CBF and/or CVR support cognitive performance and this relationship is mediated by the
presence of CSF biomarkers of AD neurodegeneration, suggesting a synergistic contribution of neurovascular
and cerebrovascular dysfunction to neurodegeneration and cognitive decline in older at-risk Veterans.] The
completion of the proposed aims will achieve the following goals that could guide future research in early
dementia detection and prevention: 1) refine the prevailing biomarker model of AD by more firmly establishing
the independent or combined contribution of neuropathological and cerebrovascular AD risk factors in the
cascade of events precipitating AD, 2) establish prognostic utility of imaging, neuropsychological,
neuropathological, and vascular biomarkers to detect cognitive decline, and 3) improve mechanistic
understanding of AD risk and identify potential therapeutic targets that will ultimately inform interventions to
prevent or delay the onset of AD.

Public health relevance
This application examines the relationship between vascular dysfunction and accumulation of amyloid-β and neurofibrillary tangles and their contribution to cognition to elucidate the neuropathogenesis of Alzheimer’s disease (AD). This study employs vascular and cerebrospinal fluid biomarker assessment, functional neuroimaging, and neuropsychological testing to reveal independent and interactive effects of vascular and neurodegenerative biomarkers on cognitive function in older Veterans at risk for cognitive decline. By elucidating the link between the vascular and neurodegenerative AD pathophysiological process and cognition, this study aims to improve a mechanistic understanding of cognitive decline and to identify therapeutic targets to prevent or delay AD.